San Diego Resource Center for advancing Alzheimer's Research in Minority Seniors (ARMS)

ABSTRACT: RESEARCH EDUCATION COMPONENT
The overarching goal of the Research Education Component (REC) for the San Diego Resource Center for
advancing Alzheimer’s Research in Minority Elders (SDRC-ARMS) is to support mentoring and research
education of Latino and other underrepresented scientists whose research is focused on illuminating the role of
biological, behavioral, sociocultural and environmental factors in the etiology and outcomes of Latino
Alzheimer’s Disease and Related Dementias (ADRD).
The REC goals are to: 1) Develop the careers of postdoctoral and junior faculty researchers, as well as mid-
career faculty researchers new to ADRD, from Latino and other underrepresented backgrounds, who have
demonstrated outstanding research potential and an interest in research focused on understanding factors that
affect etiology and outcomes in ADRD; and 2) Provide mentorship, education, career development activities
and a broad array of educational and infrastructural resources to enable AD-RCMAR Scientists to enhance
their expertise in Latino ADRD research and research methods, successfully complete their research, present
and publish their work and attain independent research and/ or career development funding.
The SDRC-ARMS will be led by four Principal Investigators (PI), two at each campus: Dr. Moore (UCSD-
Geriatrics), González (UCSD-Neurosciences), Gilbert (SDSU-Psychology) and Elder (SDSU/UCSD-Public
Health). The four PIs have complementary skills and have collaborated to develop this application using the
team science model. The SDRC-ARMS includes three cores: Administrative, Research Education, and
Analysis. It is our intention that the SDRC-ARMS and its Cores be composed of investigators who are diverse
with respect to their institutional affiliations, disciplines, and research and training skills. This diversity will
increase the SDRC-ARMS‘ effectiveness in developing a diverse workforce that can promote advances in
Latino ADRD.